Isotretinoin-Basal Cell Carcinoma Prevention Trial

Objective:. To test the effectiveness of the long-term administration of isotretinoin in reducing the occurrence of basal cell carcinoma (BCC) in patients with previously treated BCC and to measure the toxicity associated with this regimen. Background: High dose isotretinoin has been reported to have a prophylactic effect on nonmelanoma skin cancer, although it is associatedwith significant toxicity. Methods: A multicenter clinical trial was conducted at eight medicalcenters in the U.S. A total of 981 patients with two or more previously confirmed BCC wererandomly assigned to receive either 10 mg of isotretinoin or placebo daily. Patients werefollowed for 36 months on intervention and were monitored at six month intervals. Progress:The active intervention phase of the trial ended in 1990. Results showed that after 36 months ofintervention, no statistically significant treatment group differences in either the cumulative percent of patients with incident BCC or the annual rate of BCC formation were observed.Adverse effects, including axial skeletal changes, were higher in the isotretinoin treated group. This cohort of 981 men has also been used to examine the effect of baseline constitutional risk factors on the subsequent risk of basal cell carcinoma (BCC), squamous cell carcinoma of theskin (SCC), and actinic keratoses (AK). In multivariate analysis, male gender, age greater than 65 years, the number of previous BCCs, and history of SCC were predictive of all three studyoutcome measures. A manuscript documenting these results is in preparation. In addition, three nested case control studies using stored biologic specimens are at various stages. One study which examined (in collaboration with Fox Chase Cancer Center) the relation of prediagnostic levels of several serum carotenoids and subsequent risk of nonmelanoma skin cancer in the cohort has been completed and a manuscript describing the results has been published in the journal, Cancer Epidemiology, Biomarkers and Prevention. The study found that pre-diagnostic serum levels of carotenoids were not associated with subsequent risk of basal cell carcinoma. However, serum levels of lutein, zeaxanthin and beta-cryptoxanthin were found to be associated with increased risk for squamous cell carcinoma of the skin (relative risks of 1.63, 2.40 and 2.15, respectively). Another study still in the planning stages will investigate the association between polymorphisms of certain DNA repair genes (specifically, XPD, XPF, XRCC1 and XRCC3), associated DNA repair capacity and the risk of subsequent nonmelanoma skin cancer. In addition, using tumor tissue DNA, we would like to examine loss of heterozygosity of the patched gene (chromosome 9q22) and its relation to superficial multicentric basal cell carcinoma and nodular basal cell carcinoma in non-sun exposed areas of the body.